Development of non-sedative, parasite-selective benzodiazepines to treat the neglected tropical disease schistosomiasis

ABSTRACT: The neglected tropical disease schistosomiasis is caused by parasitic blood flukes that infect >230 million people worldwide. Current treatment is reliant on just one drug, praziquantel (PZQ). PZQ is ineffective against recently acquired parasites that have not reached sexual maturity. PZQ also does not kill schistosomes directly. These drawbacks, and the prospect of emerging treatment-resistant parasite strains, highlight the need for alternative therapies to control schistosomiasis. The long-term goal is to identify improved anti-schistosomal drugs. Therefore, this proposal will investigate an alternative group of compounds with proven anti-parasitic activity, benzodiazepines. Benzodiazepine leads are effective at treating schistosomiasis but have high affinity for the human GABAARs that cause sedation. The overall objective of this application is to identify derivatives of a schistocidal benzodiazepine, meclonazepam, that retain anti- parasitic activity and lack affinity for sedation-causing GABAAR sub-types. The central hypothesis is that that benzodiazepine therapies with decreased engagement of host GABAARs will minimize sedation and retain schistocidal activity. The rationale for this project is that while host sedation is driven by drug action at the α1GABAAR, schistosome genomes lack GABAARs entirely. Therefore, GABAARs cannot account for the anti- parasitic effects of benzodiazepines. Instead, preliminary data indicates that meclonazepam acts on parasite Ca2+ channels. Since the “on-target” parasite receptor and “off-target” host receptor for this drug are distinct, it should be possible to develop treatments with improved selectivity. This will be done by pursuing two specific aims: 1) Develop analogs of meclonazepam with decreased activity at mammalian α1GABAARs. 2) Block sedation in vivo by admixture of meclonazepam with α1GABAAR antagonists. Under the first aim, we will synthesize meclonazepam analogs and screen these and other sub-type selective benzodiazepines in binding assays against mammalian GABAARs. Compounds with decreased GABAAR affinity will then be screened against schistosomes to identify parasite-selective derivatives. Finally, schistocidal ligands will be screened in murine model of schistosomiasis to assess efficacy benchmarked relative to meclonazepam. In the second aim, we will assess the in vivo sedative effects of meclonazepam (as well as hits from Aim 1) and the blockade of sedation by α1GABAAR-selective antagonists. The rotarod test will be used to determine the sedating dose of each compound, which will then be administered in mixture with varying ratios of antagonists to determine an admixture that admixture clears parasites with minimized side effects. The research proposed is significant because it will advance new schistocidal leads ? no drug to treat schistosomiasis has been FDA approved since 1982. This research is innovative, combining Dr. Chan’s expertise in parasitology with the medicinal chemistry expertise of Dr. Cook, an expert in fundamental properties and pharmacology of GABAAR subtypes.

Public health relevance
PROJECT NARRATIVE The neglected tropical disease schistosomiasis infects hundreds of millions of people worldwide and is treated by just one drug, praziquantel, that does not directly kill parasites and is unable to clear recently acquired infections. We will explore an alternative class of compounds, benzodiazepines, that are directly schistocidal and capable of clearing all stages of infection, regardless of whether parasites are immature or mature. This project will develop benzodiazepine therapies with minimized side effects, such as drowsiness and sedation, enabling this lead to advance towards clinical development and aid in control of schistosomiasis as a public health problem.